Development of an Anti-Cancer Approach Through a Novel Pathway of Translational Regulation

ABSTRACT
STAT3 (Signal Transducer and Activator of Transcription 3) is a transcriptional regulator that plays crucial role
in malignant transformation of the cells, tumor growth and metastasis. STAT3 activity or expression is
upregulated in 70% of human tumors contributing to a rapid cancer progression and therefore it is a potential
pharmacological target in cancer treatments. It was demonstrated that STAT3 knockdown reduced abnormal
cell growth. However, direct and indirect inhibitors of STAT3 activity did not provide expected efficacy,
demanding search for alternative strategies for STAT3 inhibition. The presence of STAT3 aberrant expression
in different types of tumors and potential ability to treat cancer through decrease of STAT3 expression
determines high significance of the study. The central idea of the current project is based on control of STAT3
expression during its synthesis on the ribosome through modulation of components of the novel pathway
recently discovered by us. The RAPP (Regulation of Aberrant Protein Production) pathway specifically
regulates protein synthesis, degrading mRNAs of the proteins that do not properly interact during their
synthesis on the ribosome. Our hypothesis is that the RAPP translational regulators may be used to
control STAT3 expression and therefore restrict cell proliferation and tumor growth. The concept of this
type of STAT3 regulation was never explored before, little is known about STAT3 translational partners and
about their modulation to control STAT3 expression, thus demonstrating novelty of the project. Our preliminary
data demonstrate that the RAPP pathway is involved in regulation of STAT3. The following specific aims are
designed for this project: (1) identify novel STAT3 translational partners during its synthesis on the ribosome,
and (2) test the hypothesis that RAPP translational regulators can be modulated to decrease STAT3
expression and cancer cell proliferation. The study is based on unique technologies for detection and
identification of proteins during translation by site-specific photo-crosslinking and iPINCH approaches. We will
use candidate and unbiased approaches to test RAPP regulators in STAT3 control. The experiments will also
involve cell culture models and RNA interference techniques or overproduction to verify involvement of the
RAPP components in STAT3 regulation. In this project we will determine potential anti-cancer properties of the
RAPP modulation by measuring cancer cell proliferation and apoptosis. The success of the proposal will build
a foundation for the future studies with animal models and use of chemical regulators (potential drugs) to
develop new anti-cancer medicine. Potentially, this proposal will lead to development of conceptually new
directions in pharmacological treatments of cancer.

Public health relevance
PROJECT NARRATIVE Abnormal STAT3 protein expression leads to uncontrolled cell growth, cancer progression and it is associated with about 70% of all human tumors. Here we propose a pilot study to test modulation of a novel pathway of translational regulation, recently discovered by us, to decrease STAT3 synthesis and, thus, stop cancer development. Potentially, the project will lead to development of new types of anti-cancer treatments in the future.